Cores

General rationale and organization of the Cores The main potential technical barriers to efficient execution of the biology are (1) the quality control and execution of the 3-D culture system, and (2) the requirement for expertise and ready access to state of the art confocal microscopy. To make these essential technologies readily available to everybody, and to coordinate the efforts of the various groups, we propose two core facilities, one to coordinate the 3-D culture methodology (3-D Core), and another to manage the confocal microscope (Confocal Core). Although the 3- D Cell Culture and Microscope Cores will be described separately, they will be located in adjacent labs and are designed to work together to standardize data collection procedures and provide a seamless transition from the 3-D culture phase to the confocal analysis phase of each study.